Oral Pathogens and Dendritic Cell Subsets

DESCRIPTION (provided by applicant): While part of a complex biofilm, P. gingivalis is uniquely able to infect the submucosal regions of the human oral mucosa whereupon it associates in situ with the potent antigen presenting cells dendritic cells (DCs) in CP. These DCs form organized immune conjugates with CD4+ T cells, called oral lymphoid foci or OLF. The immunomodulatory functions of DCs in response to P. gingivalis infection is thus of intense interest in our laboratory. P. gingivalis expresses an unusual immunomodulatory LPS and two fimbrial adhesins: the 67 kDa mfa-1 (minor) fimbriae and the 41 kDa fimA (major) fimbriae. Our published studies indicate that the minor fimbriae of P. gingivalis targets the C-type lectin receptor DC- specific ICAM-grabbing non-integrin (DC-SIGN), for entry into DCs. P. gingivalis is taken into as yet unidentified DC-SIGN-rich intracellular compartments in large numbers, where P. gingivalis appear essentially intact and viable. Moreover, the minor fimbriae induce an immunosuppressive cytokine and costimulatory molecule profile in DCs and the DCs induce a Th2 effector response. We have now purified the native minor fimbriae and it appears to be glycosylated and forms fimbrial-like 200 nm strands, revealed by electron microscopy. The major fimbriae also enhance entry of P. gingivalis into DCs, but DC-SIGN is not involved. These DCs produce high levels of IL-12p70, IL-23 and IL-6 and induce strong CD4+ naive T cell proliferation. The T cells in response to major fimbriae appear to be Th17 cells: secreting IL-17 and IFN3. The objectives of this renewal application therefore are to determine the roles of minor and major fimbriae of P. gingivalis in the intracellular fate of P. gingivalis within human DCs (Aim 1), the signaling pathways in DCs activated by P. gingivalis (Aim 2) and the T cell effector responses elicited in DCs by P. gingivalis (Aim 3). The overall goal of these continuing studies is to identify the mechanisms for how this oral mucosal pathogen is able to persist in DCs and modulate DC-mediated immune responses.

Public health relevance
PUBLIC HEALTH RELEVANCE: Gum disease or periodontal disease is a disease of the supporting tissues of the teeth that results in early tooth loss and has been linked to increased risk for heart disease or stroke. We do not understand why periodontal disease is so difficult to treat successfully. It seems to be a lifelong infection like AIDS or in some cases tuberculosis. We think that this may be due to the ability of the bacterial species Porphyromonas gingivalis to infect the gums and evade or suppress the immune system. Our results suggest it does this by surviving within the white blood cells dendritic cells and suppressing their immune functions. The purpose of this application is to determine how this species is able to persist in dendritic cells and suppress their functions. Cutler, Christopher W. Gum disease or periodontal disease is a disease of the supporting tissues of the teeth that results in early tooth loss and has been linked to increased risk for heart disease or stroke. We do not understand why periodontal disease is so difficult to treat successfully. It seems to be a lifelong infection like AIDS or in some cases tuberculosis. We think that this may be due to the ability of the bacterial species Porphyromonas gingivalis to infect the gums and evade or suppress the immune system. Our results suggest it does this by surviving within the white blood cells dendritic cells and suppressing their immune functions. The purpose of this application is to determine how this species is able to persist in dendritic cells and suppress their functions. __SpecificAimsTextDelimiter__ Cutler, Christopher W. Specific aims Among the many bacterial species that comprise the oral biofilm, Porphyromonas gingivalis has been called a 'keystone' species due to its ability to regulate local immune responses and thereby influence the entire oral microbial community. We have shown that P. gingivalis invades the human oral submucosa and infects the potent antigen presenting cells dendritic cells (DCs) in chronic periodontitis (CP) in situ. Furthermore, these DCs form organized immune conjugates with local CD4+ T cells in oral mucosa. Similar conjugates in the gut mucosa induce T cell effector responses locally and systemically. If poorly regulated, these responses can lead to organ specific diseases such as ulcerative colitis and, as we propose, CP. However, there is little known about how oral pathogens such as P. gingvalis interact with DCs, their intracellular fate within DCs and the type of immune responses that are elicited. We have now shown that P. gingivalis enters DCs by targeting the C-type lectin receptor DC-SIGN, using its minor 67kDa mfa-1 fimbriae. This induces weak DC maturation, an immunosuppressive cytokine profile and a Th2 effector response. In contrast, the non-DC-SIGN targeting major fimbriae yields a very different DC response: high levels of IL-12p70, IL-23 and IL-6 and induction of a Th1/Th17 type response. We have now purified the native minor fimbriae from P. gingivalis by ion exchange chromatography and analyzed it by Pro-Q glycoprotein gel staining and gas chromatography-mass spectroscopy, revealing that the minor fimbriae is glycosylated with important DC-SIGN targeting sugars fucose, mannose, GalNAc and GlcNAc. The purified minor fimbriae form fimbrial-like 200 nm strands, revealed by electron microscopy, which could be involved in DC-SIGN cross-linking. We conceptualize minor fimbriae and major fimbriae as a type of 'rheostat' for regulation of DC-mediated immune effector responses by P. gingivalis; however, the mechanisms involved are presently unclear. DC-SIGN ligation, such as that by minor fimbriae, reportedly activates a unique signaling cascade, called the DC- SIGN signalosome. The DC-SIGN signalosome regulates TLR-mediated signaling pathways, such as those activated by major fimbriae, in particular the MAPKinases. These signaling pathways are important in induction of phagosomal maturation, phagolysome fusion and inflammatory cytokine profiles that determine T cell effector responses. We now show that P. gingivalis 381 is routed in large numbers, essentially intact and viable, into DC- SIGN-rich intracellular compartments, but the identity of these intracellular compartments to which P. gingivalis is routed and their mechanisms for survival inside DCs are presently unclear. We propose that DC-SIGN-TLR crosstalk in DCs, in response to minor and major fimbriae regulates: (i) DC phagosomal maturation and phagolysomal fusion, enabling P. gingivalis to survive within DCs (ii) intracellular signaling pathways and transcription factors involved in DC maturation and cytokine profiles and (iii) effector and regulatory T cell responses induced by DCs. Accordingly, our aims are: Specific aim 1: To determine the intracellular fate of P.gingivalis (Pg) within DCs. We hypothesize that minor fimbriae targeting of DC-SIGN inhibits phagosomal maturation and acidification that are activated by major fimbriae, resulting in an intracellular environment permissive for Pg survival and growth. The identity and maturation state of the phagosomes to which Pg381, its minor-, major- fimbriae deficient mutants are routed in DCs will be determined by analysis of markers of early-, late-phagosomes, phagolysosomes and phagosomal acidification within MoDCs. Intracellular survival of Pg will be determined by antibiotic protection assay. Specific aim 2: To identify signaling pathways in DCs activated by minor and major fimbriae of P.gingivalis. We hypothesize that minor and major Pg fimbriae activate distinct signaling pathways in DCs that account for their distinct immunoregulatory functions. The activation by Pg, its isogenic fimbriae deficient mutants and purified minor/major fimbriae of MAPK signaling pathways, as well as the proteins of the DC-SIGN signalosome, Raf-1 activation and NFκB p65, p50 will be determined by semi-quantitative Western blotting, quantitative FACS analysis, ELISA and EMSA. . Specific aim 3: To determine the T cell effector responses induced by DCs in response to minor and major fimbriae of P.gingivalis. We hypothesize that signaling pathways activated by minor and major fimbriae of Pg instruct DCs to polarize T cell effector responses towards Treg and Th17, respectively. DC/naïve CD4+ T cell co-cultures will be performed to analyze differentiation of Th1, Th2, Th17 effector subsets and of Treg by intracellular cytokine profiles and by their respective lineage commitment transcription factors T-bet, GATA3, FoxP3 and ROR-ct (retinoid-related orphan receptors-ct) by intracellular staining and FACS analysis. The overall goal of these continuing studies is to identify the mechanisms for how this oral mucosal pathogen is able to persist in DCs and modulate effector T cell responses. 1